Disease transmission along complex human-animal networks: a novel method for improving zoonotic disease modeling

ABSTRACT
Endemic and emerging zoonoses both represent profound threats to public health. While these two disease
systems diverge in many ways, fundamental to both is the importance contact networks in which humans and
animals mix. In STI research and veterinary epidemiology, analysis of human-only and livestock-only networks
have led to significant insights on how transmission occurs, and how best to interrupt it. Yet to our knowledge,
no prior research has modeled a human-animal contact network using empirical data, leaving the benefits of
network epidemiology inaccessible to zoonotic disease research and control. As a result, researchers must as-
sume that humans and animals mix randomly, or rely on weakly-justified assumptions about stratified risk, when
building mathematical models, designing surveillance systems, or planning interventions. There is a critical need
to characterize the structure and dynamics of human-animal contact across a range of settings and disease
systems, in order to reduce the burden of endemic zoonoses and prevent emergence of novel zoonoses. Our
long-term goal is to develop a suite of methods for conducing human-animal network analyses. Our overall
objective is to demonstrate proof-of-principle: that analysis of human-animal contact networks is feasible, and
results in improved inference. Because emergence of novel zoonotic pathogens is a rare event, we will instead
use data from four high-burden endemic zoonoses representing a range of transmission modes: brucellosis, Q
fever, leptospirosis, and anaplasmosis. This ensures we will have adequate power to achieve our objective, and
contributes to the control of high-morbidity, poverty-reinforcing diseases. Across Dornod and Uvurkhangai prov-
inces in Mongolia, we will use an egocentric approach to sampling whereby ego households are randomly se-
lected and asked to name alter households: those whose animal herd mixes with their own. In Aim 1, following
formative qualitative research we will collect empirical human-livestock contact data using surveys and livestock
GPS collars. GPS collars will be placed for five months, during which period network changes will be captured
using a monthly husbandry log (household) and a 24 hour contact diary (individual) completed once per month.
In Aim 2 we will fit a generative network model to the network data gathered in Aim 1. We will simulate synthetic
networks from this generative model, and demonstrate their validity using disease data from real-time qPCR
testing and molecular strain typing. Finally, in Aim 3 we will combine these synthetic networks and disease data
in an epidemic model of disease transmission, separately for each disease, broadly following an SEIR frame-
work. Using these models, we will evaluate the added utility gained by incorporating network structure compared
with assuming random mixing. We expect our contribution to be methods for measuring and modeling human-
animal contact networks. These will provide the necessary foundation for conducting human-animal network
analyses across a range of settings, allowing benefits to accrue through improving the validity of zoonotic disease
modeling and generating broad insights on human-animal network structure.

Public health relevance
The proposed research is relevant to public health because it proposes a new methodological approach to studying and controlling zoonotic diseases, which represent a substantial threat to public health. A validated method for measuring and modeling human-livestock contact networks is expected to have positive impact as no empirically-derived human-animal network models exist, compelling zoonotic disease modelers to make oversimplifications which limit the validity of their findings. This project is relevant to NIAID’s mission to better understand and ultimately prevent infectious diseases because it is expected to open new horizons for targeting interventions and surveillance at the human-animal interface, optimizing cost effectiveness and facilitating more timely response before substantial human-to-human transmission has occurred.